c-Ski and the regulation of CD4 T cell-mediated autoimmunity and tolerance

DESCRIPTION (provided by applicant): It is becoming clear that CD4 T cell plasticity is an important aspect of initiating and regulating immune responses. Among the factors that play a critical role in determining T cell differentiative fate is TGFβ. Recent work has shown that TGFβ, through its ability to induce the expression of both Foxp3 and RORγt, is involved in iTreg/Th17 differentiation. Exposure of CD4 T cells to antigen in the presence of TGFβ alone leads to iTreg development, while the presence of inflammation cytokines (e.g., IL-6) with TGFβ results in Th17 differentiation. Thus, the ability of TGFβ to regulate the expression of Foxp3 and RORγt based on microenvironmental cues, is a key aspect of T cell function. Factors that regulate TGFβ function are therefore important players in this process. One such factor is the proto-oncogene c-Ski. The Ski gene was first identified as v-Ski, the retroviral oncogene in Sloan-Kettering retroviruses capable of transforming chicken embryo fibroblasts. The cellular homolog, c-Ski, has been shown to be important for several aspects of embryonic development, and Ski- deficiency leads to late embryonic death. Ski functions as a natural inhibitor of the TGFβ signaling pathway by targeting several downstream signaling events. However, a role for Ski in the immune system has not been determined. Given the important role of TGFβ in regulating immune responses, a better understanding of Ski in the context of immune development and responses is important. For this work we have generated a mouse strain that contains a conditional knockout allele of Ski, allowing us to delete Ski specifically in T cells. These mice wll allow us to determine the role of Ski in T cell homeostasis and function. With this in mind, the aims of this proposal are: 1. Determine the role of Ski in regulating TGFβ-mediated effects in CD4 T cells; 2. Determine the role of Ski in regulating T cell homeostasis; 3. Determine the effect of Ski-deficiency on CD4 T cell function.

Public health relevance
PUBLIC HEALTH RELEVANCE: Identification and characterization of the factors that control the ability of the immune system to distinguish self from non-self is critical to the development o therapeutics for the treatment of autoimmune diseases. This is especially true at mucosal surfaces where the ability to distinguish between harmless environmental factors and pathogens is crucial. The cytokine TGF� is intimately involved in this process as it is critical to the differentiation of both regulatory T cells and effector T cells. Maintaining this balance is very important, and identifying other factors that influence these differentiative decisions will shed important light on this process, and define new pathways for potential therapeutic intervention.